Development of "Face-Forward-Web": A novel web-based program targeting pain-related outcomes among patients with heterogeneous chronic orofacial pain

PROJECT SUMMARY
Background: Chronic orofacial pain (COP) conditions are common, costly, and debilitating. These conditions are unified
by high levels of pain-related activity limitations, maladaptive coping and emotional distress, which are most often
unaddressed and worsen each other over time. The majority of COP treatments are biomedical, often ineffective, involve
adverse side-effects, misdiagnoses, and can entail unnecessary and painful procedures that may lead to irreversible damage.
Available psychosocial interventions are limited in effectiveness, accessibility, scalability, scope, availability of trained
providers, and insurance coverage. They also rely on talking, posing a significant barrier to participation for many
patients with COP. “Talk-free” psychosocial web-based platforms are needed to bypass these limitations and make
psychosocial treatment accessible, scalable, and generalizable but do not exist for adults with heterogenous COP.
The goal of this R21 proposal is to adapt the Relaxation Response Resiliency Program (3RP), an evidence-based program,
for the unique needs of people with COP and for asynchronous delivery through a web-based platform. We have shown that
the 3RP improves pain-related activity limitations and emotional distress among people with refractory temporomandibular
joint disorder (TMD) when delivered in person. However, to assure accessibility, generalizability, scalability, and future
efficacy, it is essential to adapt the 3RP to a “talk-free” web platform tailored to unique unmet challenges in COP.
Our guiding hypothesis (to be tested in future work) is that Face-Forward-Web will be an effective, efficient and
scalable strategy to improve pain-related activity limitations and emotional distress among patients with COP.
Specific Aims and Research Design. We will conduct live video focus groups (N=4-5 groups/ N=20 individuals) with
people who have heterogeneous COP to understand treatments needs and preferences and adapt the intervention for
asynchronous delivery via a web-based platform - Face-Forward-Web, the first of its kind for this population (aim 1); and
(2) iteratively optimize Face-Forward-Web through a series of open pilots with exit interviews (2 with N=5 and 1 with
N=10) until critical Go/No-go feasibility and acceptability benchmarks are met (aim 2).
This project aligns with NIDCR’s stated priorities of supporting research promoting craniofacial health, alleviating
discomfort, and embracing technology as a driver of discovery.
Impact: Our interdisciplinary team of psychologists, a dentist and a neurologist has partnered with the national Facial Pain
Association to collect preliminary data and facilitate recruitment for this project. We have extensive expertise with mixed
methods, development of web platforms, and remote clinical trials. Results of this study will directly inform a subsequent
UG3/UH3 NIDCR application. In the UG3 we will conduct a small pilot RCT (NIH 1B) to ensure our ability to randomize
and finalize our study protocol, including fidelity measurement. In the UH3 phase we will test the efficacy of Face-Forward-
Web in improving pain, activity limitations and emotional distress, and test theory-driven mechanisms of improvement
through adaptive coping. Face-Forward-Web, adapted specifically for the needs of this population and delivered through
their preferred modality, has the potential to improve pain, activity limitations, and emotional distress in this population.

Public health relevance
PROJECT NARRATIVE Chronic orofacial pain conditions are unified by high levels of pain-related disability, maladaptive coping (e.g., fear avoidance and catastrophic thinking about pain) and emotional distress (e.g., depression and anxiety). The proposed study will develop, iteratively refine, and establish the feasibility, acceptability and credibility of Face-Forward-Web, the first psychosocial intervention developed through mixed-methods, designed specifically for adults with heterogeneous chronic orofacial pain, and delivered through web-platform (this population’s preferred treatment modality). Face-Forward-Web bypasses key accessibility and scalability-related limitations of existing interventions (including challenges with talk- based therapy, which is often painful and limits engagement in this population) and has the potential to dramatically improve pain, pain-related activity limitations and distress in this population.